Enhancing capacity in faith-based organizations to implement and sustain multilevel innovations to improve physical activity

Abstract of funded grant or project
Despite the benefits of physical activity (PA) to prevent cardiovascular disease (CVD) and other
chronic diseases, few adult Latinas meet PA guidelines. Given the central role of faith-based
organizations (FBOs) within the Latino community and their commitment to the well-being of
their members, FBOs are ideal settings for health promotion. Evidence-based approaches for
increasing PA and reducing obesity such as Faith in Action exist, but few PA interventions go to
scale. Implementation strategies that enhance the capacity of FBO leaders and community health
workers (promotoras) to implement EBIs can facilitate their uptake. We propose to enhance
Faith in Action with three organization-level strategies designed to increase program fit and
effectiveness: 1) training FBO leaders in health promotion 2) tailoring messaging to enhance fit
between Faith in Action and each unique FBO context, and 3) empowering promotoras to
advocate for organizational change. Given the need to improve strategies to sustain health
programs in community settings, we propose to test the influence of two additional sustainment
strategies: 1) strengthening community collaborations and, 2) providing technical support. We
will conduct a hybrid type II effectiveness-implementation trial using a clustered RCT design to
test the impact of the proposed implementation strategies on organization-level change and
individual behavior in diverse FBOs for a 12-month intervention and a 6-month follow-up.
Thirty-two FBOs will be randomly assigned to a Standard EBI condition (Faith in Action as
originally implemented), an Enhanced condition (Standard condition + organizational-level
implementation strategies), or Enhanced + Sustainment condition (Enhanced implementation
condition + sustainment strategies). We will collect quantitative and qualitative data at baseline,
6 months, 12 months, and 18 months post baseline. The proposed study aims to: 1) Test the short
and long-term impacts of organization-level implementation strategies in 2 Enhanced conditions
on organizational outcomes compared to the Standard EBI condition, 2) Examine individual
reach and effectiveness among Latinas (n=812) in FBOs in the 2 Enhanced conditions compared
to the Standard EBI condition. Secondary aims examine theoretical mechanisms of action (e.g.,
organizational climate) and the additional impact of two sustainment strategies. Informed by the
Practical Robust Implementation and Sustainability Model (PRISM) and Reach Effectiveness-
Adoption Implementation and Maintenance (RE-AIM) frameworks, the current study will use
mixed methods to adapt Faith in Action to diverse FBOs. This research is innovative because it
experimentally tests organization-level implementation strategies and their associated
mechanism of action in Latino FBOs’ from diverse denominations. Our findings will impact the
field by providing rigorously derived evidence for the scale-up of innovative EBIs in FBOs. If
successful, findings from the current study will provide evidence of organizational-level
strategies for uptake, sustainment, and generalizable implementation strategies for scale-up of
PA interventions to increase PA and reduce chronic disease in FBOs across the US.

Public health relevance
See parent award.